Inhibiting mPGES-1 as a countermeasure to mitigate organophosphate-induced neurotoxicity

PROJECT SUMMARY
Exposure to organophosphate (OP) nerve agents leads to quick overstimulation of muscarinic and nicotinic
acetylcholine receptors, causing substantial mortality and morbidities associated with damages to the brain.
Current medical countermeasure drugs, such as midazolam, atropine, diazepam, and 2-PAM, are of doubtful
utility for civilian populations as they must be administered within minutes of an attack to be effective. Nor can
they prevent the long-term neurotoxicity and behavioral comorbidities due to the persistent neuroinflammation
and aggravated brain injury. Although inhibition of acetylcholinesterase is the conventional mechanism
underlying the acute neurotoxicity of OPs, several lines of evidence support essential contributions of
uncontrolled inflammation to pathogenic changes within the brain after OP intoxication, in which prostaglandin
E2 (PGE2) is widely believed to play a pivotal role. As such, blocking cyclooxygenase (COX), the enzyme
responsible for the initial step of PGE2 biosynthesis, was previously considered as a promising strategy to
reduce pathogenic PGE2 in the injured brain but turned out to be problematic due to side effects related to the
reduction in other COX-derived prostanoids that may be beneficial. In this proposal, we focus on the
microsomal prostaglandin E synthase-1 (mPGES-1), an inducible enzyme that is responsible for the terminal
step of PGE2 biosynthesis in response to various brain insults. The goal of this project is to evaluate the
feasibility of pharmacologically blocking mPGES-1 by novel, brain-penetrant, cross-species, small-molecule
inhibitors to mitigate OPs-triggered brain damage and long-term behavioral comorbidities in animals following
exposure to diisopropylfluorophosphate (DFP), the prototypical OP. Upon successful completion of this project,
we will have established a proof of concept for mPGES-1 inhibition as an effective delayed countermeasure
against the neurological sequela of cholinergic receptor hyperstimulation caused by OP agents. Anticipated
results will justify future studies on the lead optimization, efficacy, safety, and combined treatment, aiming to
develop novel therapies for OP-based nerve agents-triggered long-term neurotoxicity and functional deficits.

Public health relevance
RELEVANCE Organophosphate-based nerve agents such as sarin, soman, and venomous agent X are among the most toxic chemicals known for humankind, exposure to which can lead to high mortality and substantial morbidities in survivors. The current medical countermeasures are of doubtful utility for civilian populations as they must be administered within minutes of an attack to be effective. Proposed research aims to evaluate a novel, potent, drug-like inhibitor of an emerging therapeutic target in mice exposed to a prototypical organophosphate and may lead to a delayed treatment for nerve agents-triggered neurotoxicity and long-term neurological sequelae.